Project 2: Biomarker Analysis, Non-Genetic Risk Factors, and Their Genetic Interactions

Project 2 Summary for Overall
The overarching goal of Project 2 is to enhance clinical trial readiness for ASAC. Successful identification of
effective treatment and prevention for AD will require inclusion of all populations in clinical trials, with all
individuals having accurate diagnosis of disease. Molecular measures of AD pathology have gained increasing
traction to support clinical diagnosis of AD. Peripheral biomarkers, specifically plasma proteins that reflect AD
neuropathology, have shown increasing utility and represent an accessible opportunity to diagnose and treat AD
sooner. While no plasma biomarker has yet been approved for diagnostic use, blood biomarkers of AD
neuropathology (Aβ42/40, Tau-181), axonal injury (neurofilament light [NfL]), and astrogliosis (glial fibrillary
acidic protein [GFAP]) have shown promising utility in AD diagnosis given their strong associations with cognitive
decline, gray matter loss, and AD conversion. However, most biomarker development has been performed in
homogenous, European ancestry populations. There is an urgent need for the field to test whether AD biomarker
thresholds generalize across diverse populations, including Asians. Meanwhile, it has been reported that 40-
50% of all dementia cases can be prevented by modifiable risk factors. Again, such findings are mainly based
on studies focused mainly on European Americans and may not be generalized to ASAC. Prior studies have
shown that effect sizes, and the relative contributions, of non-genetic risk factors on AD often differ between
racial/ethnic groups. In addition, ASAC, being an ethnic minority living in North America, has unique risk profiles
for AD compared to Asians living in Asia. Numerous non-genetic factors may contribute to such differences,
including education, immigration history and acculturation level, leisure and physical activities, diet, and
psychosocial stress. Better characterizing the risk profiles has critical implications for the design of future
interventional trials for individuals with diverse ancestry, particularly for understudied groups like ASAC. To
accurately identify those at highest risk for AD and to design an effective preventive trial, we require a better
understanding of the impact of non-genetic factors on AD risk. Overall, Project 2 will address these gaps in
knowledge by leveraging the unique resources of the multi-center ACAD to determine ASAC-specific diagnostic
cut-offs for promising AD plasma biomarkers (Aβ42/40, Tau-181, NfL, and GFAP), and to investigate non-genetic
factors in conferring AD risk and in moderating the association between genetic factors and AD in ASAC. Project
2 will test the overarching hypothesis that there are ASAC-specific AD biomarker thresholds and unique non-
genetic factors that interact with genetic risk for AD. Together, through biomarkers and non-genetic factors (and
integration with genetic factors in Project 1), Project 2 will generate a significant, sustained impact on the field
by enhancing our ability to accurately profile AD risk in the ASAC community, which will be extremely valuable
information when designing new interventions to prevent AD development and progression in all populations.